Graduate Training Program in Comparative Medicine

PROJECT SUMMARY
Continued support is requested for a “Graduate Program in Comparative Medicine” at Cornell University
College of Veterinary Medicine. Six post-doctoral positions are requested to provide training to DVMs seeking
a PhD. The Comparative Medicine Program combines the very best that Cornell offers in the form of didactic
graduate-level instruction, faculty supervision, and training-related activities. Trainees will follow one of three
tracks: track 1 is geared toward a career in basic research, track 2 to a career in translational science, and
Track 3 to public health/One Health. Training for each track is structured to ensure the orderly progression of
scholars to independence. Research areas available to trainees are intentionally broad and include infectious
disease, immunology, epidemiology, cancer biology, cell biology and signal transduction, genomics and
genetics, developmental biology, molecular medicine, and neuroscience.
The proposed program combines independent, faculty-guided research with formal coursework in experimental
design, rigor, and ethics. The program also includes track-specific coursework and training in biostatistics &
computational biology. Regular professional enrichment workshops will encompass training in communication,
grant writing, and teamwork skills. Biannual workshops will discuss career options and provide career
counseling. Graduate research assistantships will provide the first nine months of training support at Cornell's
College of Veterinary Medicine. It is expected that trainees will apply for individual fellowships (“K” awards or
equivalent) that would support the trainees as they finish their graduate studies and transition to independent
careers. However, all trainers are selected to ensure training support continues independent of any fellowship
award.
We strongly encourage program alums to undertake at least two years of research beyond their Ph.D. degree,
preferably in a related discipline and at a different institution, before accepting their initial appointment as an
independent investigator. We expect most of our alums to enter careers as faculty members in U.S. veterinary
colleges or medical schools or to enter careers in government or industry. The program aims to train veterinary
scientists who can meet the national need for trained veterinarians within academia, industry, public health,
and government to address problems relating to animal and human health.

Public health relevance
PROJECT NARRATIVE The Comparative Medicine Program at Cornell University is preparing accomplished and highly motivated veterinarians for discovery-based and public health careers in basic and translational science. With a broad knowledge of comparative disease and strong intellectual and lateral thinking abilities, veterinarians with advanced scientific training are expected to play an essential role in biomedical science and public health and to promote the NIH goal of developing, maintaining, and renewing scientific human resources that will ensure the Nation’s capability to prevent disease.